Exercise, Stress Biomarkers, and Alzheimer's Disease Neuropathology

Abstract
Aerobic exercise might affect the brain through a plurality of pathways, including via modulation of the
hypothalamic-pituitary-adrenal (HPA) axis. The HPA axis regulates the release of cortisol, a glucocorticoid
hormone that is related to impaired cognitive performance, reduced brain volume and function, and increased
risk for Alzheimer’s disease (AD), including markers of AD pathophysiology. Many of the same brain regions
and cognitive domains affected by high cortisol levels are the same that are positively affected by engaging in
regular aerobic exercise. Thus, we hypothesize that aerobic exercise-induced changes in cortisol might act as
a pathway by which long-term exercise influences neurocognitive health. Further, we speculate that aerobic
exercise might influence AD neuropathology through its influence on cortisol. Addressing these gaps could
have far-reaching application for adopting exercise as a method of preventing or treating cognitive impairment.
We address these unanswered questions in this high-risk/high-reward R21 application. The proposed study will
conduct an analysis of hair cortisol concentration (HCC) in a large and uniquely well-characterized sample
of cognitively normal older adults (N=648). Hair samples have been collected and banked both before and
after a multi-site Phase III dose-response 12-month supervised randomized clinical trial of exercise titled
Investigating Gains in Neurocognition in an Intervention Trial of Exercise (IGNITE). The IGNITE study and the
banked hair samples in N=648 will serve as the basis for the proposed study. This proposal reflects an
unprecedented opportunity to determine whether aerobic exercise-induced changes to HCC statistically
mediates changes to cognition, AD neuropathology, brain volume or function, and is in line with the NIH
mission to leverage existing cohort and RCT samples for cost-effectively testing new hypotheses. Our primary
aims include: Aim 1. Examine whether exercise-induced changes in HCC statistically mediates cognitive
changes resulting from the intervention. Aim 2. Examine whether exercise-induced changes in HCC
statistically mediates exercise-related changes in hippocampal and prefrontal function and volume. Aim 3:
Examine whether changes in HCC mediates exercise associations with AD neuropathology. Aim 4: The
results from the HCC assays obtained from funding this application will be incorporated into the larger IGNITE
database and will be made available to investigators interested in exploring HCC with the rich phenotyping of
IGNITE participants.

Public health relevance
NARRATIVE In the present proposal we propose to analyze cortisol on banked hair samples collected as part of the Phase III multi-site IGNITE (Investigating Gains in Neurocognition in an Intervention Trial of Exercise) project. Our aim is to examine whether a 12-month aerobic exercise intervention induces changes in hair cortisol concentration and whether these changes statistically mediate intervention-related changes to cognitive performance, brain volume and function, and Alzheimer’s disease neuropathology.